Microtubule motors, cytoskeletal organization and cell polarity

Project Summary
The overall goal of this project is to understand how microtubule motors kinesin and dynein organize
cytoskeleton in interphase cells and, as a result, drive cell polarization. Our group recently discovered that
major motor proteins, kinesin-1 and cytoplasmic dyneins, in addition to moving many types of cargoes along
microtubules, have a new function: they define the distribution and dynamic behavior of two classes of
cytoskeletal filaments, microtubules and intermediate filaments in interphase cells. We have shown that both
microtubules and intermediate filaments are being transported as polymers by motor proteins. This transport
defines general organization of the cytoskeleton, and, as a result, cell polarity. Three biological models of
polarization studied in this proposal are: (i) Drosophila neurons, where movement of microtubules by kinesin-1
drives initial extension of axons and dendrites, and cortical dynein sorts axonal microtubules into uniformly
polarized arrays; (ii) Drosophila oocytes, where transport of microtubules by kinesin-1 drives rotation of
cytoplasm for localization of polarity determinants critical for the developing embryo, and cytoplasmic dynein
transports microtubules in nurse cells and from nurse cells to the oocyte and (iii) transport of intermediate
filaments along microtubules in mammalian cells, which is important for directed cell migration.

Public health relevance
Project Narrative Cell polarity is of utmost importance for development of a multicellular organism. Polarity is generated by targeted positioning of cytoskeletal elements and directed delivery and anchoring of specific proteins and RNA. These processes are the result of action of molecular motor moving on microtubules and actin cytoskeleton. Motors, cytoskeletal filaments and their cargoes are potential targets for new drugs that could potentially be used to treat developmental and neurodegenerative diseases.